Antagonistic actions of IRF4 and BACH2 in regulating Germinal Center B cell fates and promoting Lymphomagenesis

PROJECT SUMMARY/ABSTRACT
Despite a characteristic indolent course, a substantial subset of follicular lymphoma (FL) patients has an early
relapse with a poor outcome. Thus far, efforts to identify factors that predict survival have been unsuccessful.
We found that FL patients with a worse prognosis display an increased expression of IRF4. While IRF4 normally
promotes terminal differentiation of B cells to plasma cells, its overexpression in FL B cells dysregulates immune
signaling and induces an immunosuppressive microenvironment. Our preliminary data show that IRF4 controls
the expression of multiple immune recognition molecules, suggesting its role in modulating the interaction
between B and T cells. Additionally, silencing of IRF4 in vitro and in vivo led to memory B cell (MB) transcriptional
reprogramming and cell differentiation. At the molecular level, there was an inverse correlation between IRF4
and the MB transcription factor (TF) BACH2, suggesting that their mutual antagonism may dictate cell fate. We
hypothesize that IRF4 controls B cell fate in counterbalance with BACH2, and disruption of this mechanism
promotes lymphomagenesis. To test our hypothesis, we propose two specific aims. In Aim 1 we will use new
transgenic mouse models with overexpression and deletion of irf4 in germinal center B cells to investigate
whether and how IRF4 counteracts BACH2 to define B cell fates by integrating single-cell transcriptional/protein
(CITE-seq) analysis and DNA-binding (CUT&RUN), the latter to identify IRF4 and BACH2 target genes. In Aim
2 we will perform CITE-seq and CUT&RUN of malignant B cells from the transgenic mouse models in Aim 1 to
elucidate whether the imbalance between IRF4 and BACH2 promotes lymphomagenesis. These findings will be
validated using single cell RNA-seq of human FL tumors. Our study will provide critical insights into normal B cell
differentiation as well as lymphomagenesis mediated by IRF4 dysregulation and may uncover novel therapeutic
targets.

Public health relevance
PROJECT NARRATIVE A substantial subset of follicular lymphoma (FL) patients has an early relapse and a poor clinical outcome; however, little is known of the molecular mechanisms responsible for these aggressive features. We have found that the FL patients with a worse prognosis display an increased expression of IRF4 with a distinctive plasma cell signature and a suppressive tumor microenvironment. In this project, we aim to elucidate the mechanisms by which IRF4 controls B cell fate and induces lymphomagenesis, ultimately paving the way for novel precision therapies for this unfavorable patient population.